Postdoctoral Research Training in Biotherapy of Cancer

Abstract
This proposal is the third renewal for a T32 training program for the Division of Surgical Oncology at the University
of Pittsburgh. The singular goal of this program is to prepare surgeons for a career as translational scientists in
the field of biologic therapy of cancer. We will pursue this goal by providing the trainees with an immersive
experience that will stress three core proficiencies necessary to be a successful translational scientist 1) Basic
laboratory research skills. 2) Fundamental principles of clinical investigation 3) Pragmatic experience in clinical
trial management. At the completion of this training program the surgical trainee will be uniquely prepared to
bridge the gap between clinical and laboratory research. Our expectation is that this will enhance their ability to
compete for positions and funding in their first faculty position. The applicant pool will include surgical residents
(largely from University of Pittsburgh) who are interested in surgical oncology. In addition to a thorough and
innovative training program, we also developed a comprehensive plan for training in responsible conduct of
clinical research and methods for enhancing reproducibility. We have included an aggressive approach to
recruitment and retention of under-represented minorities. Given the long and proven track record of our surgical
oncology faculty in performing cutting edge translational research this program is uniquely positioned to fill an
important societal gap in training and supporting surgeon scientists.

Public health relevance
Project Narrative Surgical oncologists have a long and important history of contributions to the field of oncology as translational scientists. However, surgeons are increasingly being underrepresented in translational research and there has been a call to address this shortage. This training program is uniquely designed to prepare surgeons for a career in translational science to maximize their ability to make meaningful contributions to society though advancing our understanding and treatment of cancer.